Novel Methods to Inform HIV/TB Clinical Trial Development

During the first 3.5 years of this R37 cycle, Novel Methods to Inform HIV/TB Clinical Trial Development
has used decision science methodologies, focusing on value of information, and demonstrated
outstanding productivity, methods expansion, trainee development, policy impact, and international
collaboration. As we complete this cycle and look forward to the subsequent one, we will continue to
develop and utilize novel VOI methods, applying them to ongoing and new international trial activities with
the following specific aims:
1) To calculate the expected value of sample information (ESVI) using generalized additive models
(GAMs) within the Monte Carlo simulation of the Cost-effectiveness of Preventing AIDS Complications
(CEPAC) model.
2) To expand upon the methods developed in Aim 1 to inform new clinical trial design, post-trial
evaluation, and priority setting in the areas of HIV and TB in South Africa, focusing on newly reported and
potential high-impact trials. We will focus on three areas:
i. Antiretroviral Treatment Strategies
ii. Vaccines and Antibody-Mediated Prevention
iii. Novel Tuberculosis Diagnostic, Treatment, and Vaccination Strategies
We anticipate continued major productivity in the next R37 cycle, informing decision makers on efficient
use of resources both in the implementation of trial results once already performed and in the conduct of
those being designed.
RELEVANCE (See instructions):
HIV and TB remain high among the top ten causes of death in low-income countries. Given the budgetary
constraints to conduct the array of ongoing and potential clinical trials, we have developed a Value of
Information (VOI) framework to assess a priori which trials might provide the best value, formally
comparing courses of action with and without new information – as might be obtained from a trial – to
quantify the value of information acquisition, accounting for both the trial benefits and costs.

Public health relevance
HIV and TB remain high among the top ten causes of death in low-income countries. Given the budgetary constraints to conduct the array of ongoing and potential clinical trials, we have developed a Value of Information (VOI) framework to assess a priori which trials might provide the best value, formally comparing courses of action with and without new information – as might be obtained from a trial – to quantify the value of information acquisition, accounting for both the trial benefits and costs.